Ikaros regulation: study on hemo-lymphopoiesis

Abstract
We test the hypothesis that IKAROS establishes chromatin configurations and spatial
organization that support lymphoid lineage priming while it maintains and refines these
configurations to effect later cell fate restrictions and ultimately provide proper effector cell
function.
In Aim 1, we study the mechanisms of lineage priming and commitment, as HSCs and multipotent
progenitors traverse functionally distinct differentiation pathways. We characterize early
developmental trajectories based on chromatin accessibility and gene expression at the single
cell level and test how these are influenced by IKAROS. Regulatory elements and networks of
transcription factors (TFs) that operate through these genomic sites are identified and validated
by complementary chromatin-based approaches that also examine how chromatin activity of
these elements and factors is influenced by IKAROS. We evaluate the contribution of IKAROS-
collaborating or -competing factors to the loss-of-IKAROS phenotypes. We finally examine how
3D genome organization is controlled by IKAROS at the root of the hemo-lymphoid system.
In Aim 2, we focus on how progenitor plasticity is controlled by establishing and maintaining
lineage-appropriate epigenomic configurations and whether these can be fully restored after
disruption. We exploit a newly developed mAID-IKAROS/OsTIR to study the order of events on
chromatin disruption and re-organization. We examine whether duration of the mutant state
imposes temporal constraints on successful restoration of wild type behavior. We test IKAROS’
role in retrograde differentiation from immature B to small pre-B cells for receptor editing. We
examine the effects of acute IKAROS depletion in vivo over a broad spectrum of the hematopoietic
lineage, with a focus on cells responsible for long-term maintenance. We then directly compare
the effects of this highly specific depletion of IKAROS to IMID drugs used to deplete IKAROS
family members to treat hematopoietic malignancies using humanized Cereblon mouse models.
Successful completion of this work provides fundamental knowledge about how the genome is
configured to support orderly development within a lineage. It has actionable implications for
efforts to treat human diseases caused or exacerbated by IKAROS loss (BALL), sustained by
IKAROS activity (MM), or where efforts to harness cells for immunotherapy are impacted by
IKAROS-regulated effector state transitions.

Public health relevance
Narrative Studies on the epigenetic mechanisms by which IKAROS and its family members control the choice of cell fate from the early steps of hematopoiesis to late stages of lymphocyte differentiation continue to make ground-breaking contributions to basic lymphocyte biology. We study how the genome is configured to support normal development of the hematopoietic system, how this is perturbed when IKAROS is removed, and whether the pathological consequences of IKAROS loss at the cellular and molecular level can be reversed by restoration of IKAROS function. Understanding how lineage-specific chromatin-based regulatory mechanisms support normal developmental progression and how they are perturbed by IKAROS loss will continue to contribute to the diagnosis, prognosis, and treatment of a wide range of hematological and immune cell diseases and holds potential for improving immune cell-based therapies.